Improving the outcomes of adolescents with ADHD via a pre-visit question prompt list/video intervention: a randomized controlled feasibility trial

Abstract
Attention-deficit/hyperactivity (ADHD) disorder is one of the most prevalent mental health conditions among
youth and the majority are cared for in primary care. Prior work indicates that youth with ADHD have poorer
functioning than youth without ADHD. The Institute of Medicine emphasizes the importance of family
engagement during visits. Simple interventions that are easy to implement are needed to engage youth and
parents more during ADHD pediatric visits. We were one of the first research teams to use question prompt
lists with youth. We found that a youth asthma question prompt list/video intervention significantly increased
youth question-asking and provider education. We also found that youth who received the intervention and
asked their providers questions were significantly more likely to have improved asthma control at 12 months.
We propose to test having both youth and parents receive an ADHD question prompt list and watch a short
video on the importance of being involved in ADHD visits. The rationale for having prompt lists for both youth
and parents is that in contrast to asthma visits where parents tended to ask questions and youth did not, in our
prior ADHD work, very few youth or parents asked questions. Yet, youth reported having an average of 8
questions about ADHD and parents an average of 8.9 questions. Using Social Cognitive Theory as a guide, we
propose to conduct a pilot randomized controlled feasibility trial of the intervention. We will enroll 140 English-
speaking youth ages 11-17 with an ADHD medical record diagnosis who screen as having predominantly
inattentive subtype, hyperactive/impulsive subtype, or combined inattention/hyperactivity on the Vanderbilt
assessment scale from three pediatric clinics. We will randomize the families to receive both the question
prompt lists and video (N=35), just the question prompt lists (N=35), just the video (N=35), or usual care
(N=35). This will allow us to understand whether both the video and question prompt list parts are needed in
the larger trial. The aims of our trial will be: (1) To examine whether the ADHD question prompt lists and/or pre-
visit video significantly impact the proposed mechanisms of the intervention. We will investigate whether
adolescents and parents in each of the intervention groups: (a) ask more questions and receive more provider
education about ADHD during their baseline and 3 month visits and (b) have higher self-efficacy at 3 and 6
months than adolescents and parents in the usual care group. (2) To investigate the effectiveness of the ADHD
question prompt lists and/or the pre-visit video by examining whether adolescents in each of the intervention
groups have improved ADHD symptoms, school and social performance, and quality-of-life at 6 months
compared to those in the usual care group. (3) Assess adolescent, parent, and provider feedback on the
acceptability, feasibility, tolerability, and safety of using the ADHD question prompt lists and/or the pre-visit
video. The results from this pilot trial will be used to: (a) identify the intervention arm with the greatest potential
impact and (b) determine the best mechanisms and outcome variables to assess in a larger trial.

Public health relevance
Project Narrative The primary goal of this research is to conduct a randomized, controlled feasibility trial to investigate whether ADHD question prompt lists, a pre-visit video, or ADHD question prompt lists and a pre-visit video improve communication during pediatric visits which in turn improves adolescent ADHD symptoms, school and social performance, and quality-of-life compared to those in the usual care group. The findings will be used to plan a larger trial. If successful, this intervention could be easily disseminated to pediatric practices across the country, improving the health of adolescents with ADHD.